Mechanisms of age-related lung inflammation in pulmonary melioidosis

PROJECT SUMMARY
Lower respiratory tract infections, including pneumonia, are the most common cause of infection-related death
worldwide. Melioidosis is a frequently fatal tropical infection caused by the Tier 1 select agent Burkholderia
pseudomallei (Bp). Pulmonary melioidosis manifests in 50% of cases and doubles the risk of death. For the
first time, domestically acquired cases of melioidosis were recently reported in the United States, highlighting
the emerging nature of this severe infection. Pathogen inhalation is considered the most lethal route of
infection, and bacteria aerosolization remains a grave bioterrorism threat. As an intracellular pathogen, Bp
replicates in host immune cells, including monocytes, alveolar macrophages, and neutrophils. Activation of the
inflammasome, an intracellular sensing protein complex, is therefore thought to be critical to host defense
against Bp, leading to IL-1β production as well as pyroptosis. Neutrophil influx to the lung is mediated by
monocyte and macrophage-derived IL-1β but can be pathogenic in melioidosis, leading to tissue destruction
and ineffective bacterial clearance. Compared to adults, children make up only 5-15% of melioidosis cases and
more commonly present with cutaneous infections or abscesses. However, little is known regarding the
reasons for these differing characteristics. Using pediatric models of melioidosis, we have found that the
juvenile host has resistance to pulmonary melioidosis, highlighted by decreased early neutrophil recruitment
and lung IL-1β but increased lung monocytes. We hypothesize that pediatric host resistance to pulmonary
melioidosis is dependent on an attenuated early monocyte response leading to reduced pathologic
inflammation and improved bacterial clearance. To test these hypotheses, we will leverage in vivo and ex
vivo models of pulmonary melioidosis as well as our expertise in innate immunity and pediatric pneumonia to
undertake the following specific aims: Aim 1. Determine whether monocyte function impacts age-dependent
neutrophilic inflammation in the lung in a murine model of pulmonary infection; Aim 2. Define age-dependent
immune responses and the contribution of the inflammasome in a human lung model of pulmonary melioidosis.
Completion of these aims will elucidate mechanisms driving resistance to pulmonary melioidosis in the juvenile
host. Using age-appropriate models of lung infection, we are positioned to identify new modifiable targets for
future treatment strategies.

Public health relevance
PROJECT NARRATIVE Lower respiratory tract infections, such as community-acquired pneumonia, represent a major cause of hospitalization and death worldwide. This project seeks to understand the role of specific cells of the immune system, termed innate-like lymphocytes, in early pneumonia. The results of this proposal will provide the basis for new treatments and management approaches for severe pneumonia.